High Resolution Research Ultrasound

Project Summary/Abstract
Funds are requested to purchase a VisualSonics Vevo F2® high resolution research ultrasound imaging
system for the Cardiovascular Phenotype Core at the University of Iowa, which has been in continuous
operation since 1997. In the time since, the Core has provided over 40,000 imaging studies in mice and
rats, and has introduced a number of novel methods for assessment of organ structure and function in
vivo. In 2010, a Vevo 2100 system was purchased with NIH funds. Usage of that instrument has exceeded
projections by > 50%; reaching > 4000 studies per year, in support of researchers from the University of
Iowa College of Medicine and College of Dentistry. The vendor no longer supports or services the Vevo
2100 line of instruments. Vevo 2100 equipment failures have been rare but consequential, including
meltdown of its central processing unit in 2021. Accommodation of new users, along with existing users,
would not have been, and will not be, possible without prompt expert vendor service.
The requested instrument will reside in Cardiovascular Phenotype Core space, which is already configured
for that purpose, administered by the PI (Weiss). The University of Iowa Carver College of Medicine
(UICCOM) will fund the instrument's service contract for 5 years after the initial one-year warranty expires,
and will maintain necessary space and infrastructure without charges to the Core. The Cardiovascular
Research Center will provide funds for faculty, a trainee, and one research assistant. Critically, all fixed
costs of operation of the instrument will be underwritten by the institution. Users of the instrument will thus
only be charged for variable costs of operation, which will be limited to sonographic technologist hourly wage
plus consumable supplies necessary for imaging studies.
In summary, funds are requested to support the urgent need to replace an obsolete, heretofore
highly productive, high-resolution ultrasonograph, to support 15 NIH-funded research projects
representing 6 departments in the University of Iowa Carver College of Medicine, one
department each in the UI Colleges of Dentistry and Engineering, and the School of Engineering
at University of Colorado-Boulder.

Public health relevance
Project Narrative Funding is requested to purchase equipment to study cardiovascular function in animals which display salient genetic and physiologic features of human disease states. Application of this equipment will lead to improved understanding of the causes of and treatments for diseases which cause major morbidity and mortality in humans.